Development of bioinspired tandem semiconductor/peroxidase systems for microbiocidal applications.

ABSTRACT
Microbial biofilms are a significant source of microbial infections and represent an ongoing burden to the
healthcare industry. Recent studies indicate that an estimated 65% - 80% of all bacterial infections derive from
biofilm formation. In the case of topical infections, biofilm formation is associated with wound chronicity. Indeed,
it has been reported that microbial biofilm is present in over 90% of wounds that are chronic in nature or are
otherwise slow to heal. These chronic wounds affect an estimated 2% of the total population of the United States,
annually. The global annual cost for medical care associated with chronic wounds is predicted to reach $3.5
billion this year. Taken in total, it is clear that there is an urgent need to develop new strategies to both prevent
new biofilm formation as well as combat established biofilms. The metal-free semiconductor graphitic carbon
nitride (g-C3N4) is an attractive target for the development of such technologies due to its’ established ability to
efficiently reduce elemental oxygen to generate a variety of reactive oxygen species (ROS), including the
superoxide radical anion (O2-) and hydrogen peroxide (H2O2). This activity effectively mimics the oxidative burst
exhibited by neutrophils as part of the mammalian immune response to invasive organisms. Notably, the
antimicrobial activity of ROS, including H2O2, can be enhanced several orders of magnitude via conversion into
a variety of reactive halogen species (RHS), including HOCl, HOI and others. The reactive nature of ROS/RHS
may also impact a variety of population-dependent events by interrupting microbial quorum signaling processes.
Taking inspiration from this activity, we hypothesize that tandem g-C3N4/peroxidase systems, which directly
couple the efficient photochemical ROS formation of the semiconductor with a secondary halogenation
step, will exhibit enhanced utility for antimicrobial, anti-biofilm and anti-quorum sensing applications.
To facilitate the successful development of these new microbiocidal agents, experiments included as part of
Specific Aim 1 will be directed toward the synthesis and characterization of a series of tandem g-C3N4/peroxidase
systems that demonstrate efficient formation of ROS and RHS. Successful production of the desired RHS will
be confirmed by a combination of spectrophotometric assays and molecular trapping experiments. Experiments
in Aim 2 will serve to validate the utility of the tandem g-C3N4/peroxidase systems for microbiocidal, anti-biofilm
and anti-quorum sensing applications. Complementary mechanistic and mammalian cell toxicity studies will
provide critical information about the relative utility of the broader class of organic semiconductors, including g-
C3N4, for biomedical and antimicrobial applications. All of the experiments described in this proposal will directly
incorporate undergraduate student researchers, who have been responsible for generating much of the
preliminary data that is presented here. Taken in total, the experiments that are incorporated into this proposal
will serve to establish the biomedical utility of g-C3N4-based materials and other, related organic semiconductors
as novel functional devices capable of combatting microbial biofilms and chronic infections.

Public health relevance
PROJECT NARRATIVE The work described in this proposal will facilitate the development of bioinspired tandem g-C3N4/peroxidase systems for antibacterial, anti-biofilm and anti-quorum sensing applications. Complementary cell toxicity experiments will further establish the utility of these systems as novel microbiocidal agents. Moreover, the interdisciplinary nature of the described project will allow it to serve as a unique, integrated, high impact educational experience in which undergraduate students from the College of Idaho and Boise State University explore the design, fabrication and validation of functional materials for biomedical applications.